GBCC 2025: Genomic Data Science and Beyond with Galaxy and Bioconductor

Project Summary
The GBCC2025 conference, "Genomic Data Science and Beyond with Galaxy and
Bioconductor," aims to bridge the gap in integrating genomic data, tools, and communities. With
the rapid advancements in genomic science generating an ever-increasing volume of data and
analysis methods, there is a critical need for robust, accessible tools and collaborative platforms
to facilitate data analysis and interpretation. Despite significant progress, substantial gaps
remain in fostering environments where new analysis methods are readily developed,
incorporated, and utilized, hindering the ability to achieve medical breakthroughs that improve
human health.
Galaxy’s user-friendly web platform and Bioconductor’s comprehensive suite of R-based
genomic data analysis tools offer complementary strengths that, when combined, provide
powerful, unified solutions for the genomic research community. This joint conference will
enhance interoperability, promote innovative workflows, improve training and education, enrich
documentation efforts, and ultimately accelerate discoveries in genomic science.
The specific aims of the GBCC2025 conference are to: 1) Foster collaboration and innovation in
genomic data science by organizing sessions that demonstrate the integration of Bioconductor
tools into the Galaxy platform, enhancing interoperability and streamlining data analysis
workflows; 2) Enhance training and education by offering structured training opportunities and
hands-on workshops, including collaborative tutorials; and 3) Strengthen community and
networking among genomic researchers by facilitating unified poster sessions and shared
community networking events.
By addressing the critical need for integrated genomic data, tools, and communities through
these aims, the GBCC 2025 conference will enhance collaboration, improve training and
education, and strengthen the genomic research community, ultimately accelerating discoveries
in genomic science and contributing to medical breakthroughs that improve human health.

Public health relevance
Project Narrative The GBCC2025 conference (“Genomic Data Science and Beyond with Galaxy and Bioconductor”) will enhance the integration of genomic data, tools, and communities, addressing critical gaps in genomic data science. By fostering collaboration between the Galaxy and Bioconductor communities, plus others interested in genomic data science, the conference will improve interoperability, promote innovative workflows, and enhance training and education. This will accelerate discoveries in genomic science and contribute to medical breakthroughs that improve human health.